NBER Center for Aging and Health Research-ADRD Care at Nursing Homes During COVID

OTHER PROJECT INFORMATION – Project Summary/Abstract
The Changing Landscape of AD/ADRD Care at Nursing Homes During the COVID-19 Pandemic
This supplement examines the long-term impact of the COVID-19 pandemic on the characteristics, quality, and
racial/ethnic inequities in nursing home care for individuals with Alzheimer Disease or Alzheimer’s Disease-
Related Dementia’s (AD/ADRD). Many of the deficiencies in care delivery that existed prior to the pandemic at
some facilities – understaffing, lack of a strong clinician presence onsite, overuse of physical and chemical (i.e.,
antipsychotic medications) restraints, frequent transfers to the hospital, and high rates of falls and pressure
ulcers – may have been compounded by the pandemic, as facilities implemented new infection control practices
and visitor restrictions, alongside dealing with COVID protections (and infections) among staff, and worsening
staff shortages. These impacts were likely particularly acute for nursing home residents with AD/ADRD, who are
especially vulnerable and difficult to protect from COVID, since adherence to masking, physical distancing, and
isolation protocols is more difficult for those with cognitive and memory deficits. We will first analyze the key
aspects of nursing home care affecting health outcomes for residents with AD/ADRD at baseline, prior to the
COVID-19 pandemic. Key features of a facility include its staffing levels, composition, and consistency of staff
assignment; financial resources and management; facility layout, infrastructure, availability of private rooms, and
performance on health inspections and other quality measures. Important health outcomes for AD/ADRD
residents include hospitalizations, mortality, cognitive function, mood, and behavioral issues. Second, we will
analyze how these same key aspects of nursing home care for residents with ADRD changed during (and after)
the COVID-19 pandemic. We will also examine how the pandemic affected pre-existing disparities along racial,
ethnic, and socioeconomic dimensions in access to and receipt of high-quality SNF care for individuals with
AD/ADRD. In particular, we will examine whether pandemic driven changes in nursing home functioning (e.g.,
staffing levels, staffing experience, and financial health) have contributed to widening disparities in access and
quality. The parent grant, NBER Center for Aging and Health Research, supports new research development on
important questions relating to health at older ages. While the parent grant is not focused on Alzheimer's
Disease, this supplement would add to a growing collection of Center-supported research activity on long-term
care, and health care inequities, particularly among those with cognitive decline.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative The COVID-19 pandemic had both immediate and long-term implications for the delivery of long-term care for people with Alzheimer’s Disease and Related Dementias. This project analyzes the changes in nursing home care specifically, before, during, and after the pandemic, including key features of nursing home facilities and staffing, care characteristics and quality, inequities, and health outcomes for residents with AD/ADRD.